Vanderbilt Alzheimer's Disease Research Center: Admin Core

PROJECT SUMMARY – ADMINISTRATIVE CORE
The Vanderbilt Alzheimer’s Disease Research Center (VADRC) Administrative Core will serve as the
institutional hub for all local Alzheimer’s disease (AD) and related dementias (ADRD) research, helping all
Cores achieve the mission of characterizing how vascular risk and disease intersect with ADRD at the cellular,
systems biological, and population levels. The Administrative Core will harness institutional, philanthropic, and
P30 resources to provide excellent administrative oversight and infrastructure, ensuring that all programmatic
objectives are met, and coordinating and integrating activities across all VADRC cores and components. The
Administrative Core will establish and facilitate the administrative structure, Center governance, and oversight
of Center operations. This work includes coordinating all fiscal, operational, and regulatory functions across the
VADRC cores and components, as well as providing Center oversight and enabling optimal utilization of
resources through the Executive Committee, Scientific Review Committee, Internal and External Advisory
Committees, and Community Advisory Council. The Administrative Core will provide the strategic planning,
scientific direction, campus-wide integration, and essential infrastructure necessary to support the Center’s
organization. Interdisciplinary engagement and dynamic interactions among VADRC collaborators across
Vanderbilt University, Vanderbilt University Medical Center, and Meharry Medical College will be encouraged
through frequent meetings, innovation sessions, campus-wide events, and grant writing workshops. To
advance the goals of the National Alzheimer’s Project Act, the Core will actively support local studies and
contribute to collaborative national and international research and resource sharing initiatives (e.g., National
Alzheimer’s Coordinating Center, National Centralized Repository for ADRD, and National Institute on Aging
Genetics of AD Data Storage Site). The Administrative Core, in collaboration with the Data Management and
Statistical Core, will enhance our scalable data sharing platform to serve local, national, and international
investigator needs. Finally, the Administrative Core will be integral in recruiting new faculty and fostering the
professional development of early career clinicians, scientists, and the next generation of leaders in ADRD.
Collectively, the VADRC Administrative Core will be instrumental in facilitating integration among all Center
investigators, collaborators, component functions, resources, and national and international partners, which will
enable the VADRC to fulfill its mission.